AMINOGUANIDINE IN DIABETIC PATIENTS WITH OVERT DIABETIC NEPHROPATHY

The primary objective of this study is to evaluate the safety and efficacy of aminoguanidine in preserving renal function in patients with insulin dependent diabetes mellitus and overt diabetic nephropathy.